Aging and Development

PROJECT SUMMARY/ABSTRACT
This competitive renewal is to continue the Aging and Development Training program in
the Department of Psychological & Brain Sciences at Washington University. As the
population of the US and many other countries shifts toward an older distribution, the
scientific and societal challenges of human aging continue to increase. There is a critical
need for researchers with a firm foundation of training in the behavioral and
psychological characteristics of aging, and for these researchers to have the cutting-
edge skills to integrate neurobiology, genetics, and socioemotional mechanisms of aging
into their work. This renewal builds on the program's unique role as a pipeline of aging
researchers with a rigorous training in psychological science, while building
transdisciplinary bridges. With this renewal a core group of 20 Faculty in the Department
are joined by 13 faculty with primary appointments in the Medical School, the Brown
School of Social Work, and the McKelvey School of Engineering to serve as program
mentors. Training is organized around four interrelated themes: cognitive changes in
aging, the cognitive neuroscience of aging and dementia, personality and socio-
emotional aging, and translational impact. Trainees will receive in-depth training in one
to two themes and broad exposure to the others. The program trains both clinical and
non-clinical PhD students, and postdoctoral fellows. Trainees benefit from the excellent
resources in the Department and across the University, including those of the Charles
and Joanne Knight Alzheimer Disease Research Center and the Harvey A. Friedman
Center for Aging. In this proposal we document the high quality of the program trainees
and faculty, the structure of its well-established training program and its assessment,
and the program's track record of success.

Public health relevance
PROJECT NARRATIVE The Aging and Development Training program at Washington University provides state- of-the art predoctoral and postdoctoral training in the psychological science of human aging. The program is distinctive in its focus on psychological and behavioral science, while providing intentional interdisciplinary instruction in the biology and sociocultural aspects of human aging. Grounded in the highly-ranked Department of Psychological & Brain Sciences, the program draws on faculty from across Washington University.